Delaware INBRE DRPP Core

Project summary – Developmental Research Project Program
The Delaware INBRE (DE-INBRE) Developmental Research Project Program (DRPP), in collaboration with the
DE-INBRE administrative (ADMIN) core, develops Delaware’s junior (new and early stage) investigators into
established scientists. ADMIN supports faculty/scientist education in grantsmanship, research compliance,
laboratory management, and effective mentoring of research staff and students. DRPP supports faculty and
clinician scientist research education by identifying new investigators interested in developing research careers
by direct outreach in collaboration with DE-INBRE partner institution leadership. Identified investigators are
provided NIH grant application workshops and educated on the purpose and goals of DE-INBRE DRPP
funding mechanisms. Investigators intending to pursue DRPP funding are matched with established research
mentors with the subject matter expertise needed to mentor the junior investigator’s DRPP application and
subsequent funded research activities. DRPP, through its Research Development Committee (RDC), then
oversees NIH-style peer review of received applications, and recommends meritorious applications to the DE-
INBRE PD/PI for potential funding. Selected investigators are then mentored through the research compliance
process (IACUC and IRB approvals), and upon NIH approval, perform their funded research with the support of
their mentor, with additional mentoring/oversight from the DRPP director, the RDC, the DE-INBRE PD/PI, and
the DE-INBRE external advisory committee. ADMIN supports intensive NIH grantsmanship training for all
funded faculty/scientists while the mentoring team helps the investigator to identify/compete for appropriate
downstream funding mechanisms.